Metabolomics of Food Allergen Immunotherapy

PROJECT SUMMARY
Rates of potentially life-threatening IgE mediated food allergy continue to rise, and therapeutic options are
limited. Understanding how to alter immune tolerance in patients with food allergy is paramount to the
development of new therapies. Two types of food allergen immunotherapy, oral immunotherapy (OIT) and
sublingual immunotherapy (SLIT), rely on the administration of gradually increasing amounts of allergen to
induce tolerance. For some children, these therapies can induce a state described as remission, where the
protection against allergic reactions lasts weeks to months after stopping therapy. While current research has
focused on the adaptive immune responses to immunotherapy, the immunologic milieu necessary for these
responses is not known. Using metabolomic profiling, the large-scale quantification of metabolites by mass-
spectrometry, we identified 3 major pathways (bile acids, arachidonic acids, and histidine metabolites) with
known roles in modulating T cell biology that differentiate children who develop remission versus those who do
not. The overall goal of this proposal is to determine the role that immunomodulatory metabolites play in the
remission of food allergies induced by immunotherapy. In Aim 1, we will validate the presence of protective
metabolomic signatures of bile acids, arachidonic acids, and histidine pathways in remission using samples
from an interventional trial of OIT in young children. We will then assess how these metabolites change with
immune biomarkers of remission (serology, basophil reactivity, and T cell cytokines). While there are many
similarities in the mechanisms of OIT and SLIT, there is growing evidence for differences in the
pathophysiology of remission induced by these two types of immunotherapy. Based on this, we will study the
immunometabolism of remission in SLIT in Aim 2. Using samples from an interventional trial of SLIT, we will
characterize the presence of these three immunomodulatory metabolite pathways in remission and assess
how these pathways relate to immune biomarkers of remission. Finally, we will compare the metabolomic
profiles of SLIT and OIT to identify shared and disparate pathways between the two types of therapy. We
anticipate that this work will identify mechanisms of allergic tolerance in immunotherapy and inform the
development of new therapies.

Public health relevance
PROJECT NARRATIVE Food allergies are a potentially life threatening disease with increasing prevalence, and while oral immunotherapy and sublingual immunotherapy are two therapies that can modify this disease, outcomes are extremely variable. Our research studies protein breakdown products called metabolites, and we found that children who develop remission of their food allergies on oral immunotherapy have higher levels of bile acids and other metabolites that are known to alter the immune system. Using studies of oral immunotherapy and sublingual immunotherapy in younger children, we will study changes in these bile acids and other metabolites that affect the immune system to learn more about how children develop remission of their food allergies and identify new targets for food allergy therapies.